Enrichment Program

ENRICHMENT PROGRAM: PROJECT SUMMARY
The Enrichment Program is directed by Atul Bhan, with Kate Jeffrey serving as associate director. In these
roles, Drs. Bhan and Jeffrey will review and make recommendations for the proposed speakers and topics of the
CSIBD Research Seminar Series, the annual Symposium and Workshop, and the annual Current Techniques
in Molecular Genetics course. They will ensure that the goals of the Enrichment Program are met, in conjunction
with oversight from the Center’s Administrative Committee.
Enrichment Program activities provide the CSIBD with both institutional and extramural identity. The program
fortifies the Center’s research environment by introducing new information and new scientific approaches to
regional research teams and establishing an outlet for communication of advancements with the larger CSIBD
and Boston area scientific communities. The program enhances a scientific milieu by providing constructive
feedback to Center investigators and motivating young investigators to pursue digestive disease research. The
specific aims of the Enrichment Program are to (1) provide a comprehensive program of education and
training to members of the CSIBD; (2) ensure that investigators are aware of the latest research relevant to the
overall scientific mission of the Center; and (3) foster collaboration and interaction among CSIBD investigators.